Defining and then Maximizing the Footprint of CTL Selection on HIV Integration Site Landscapes to Optimize Cure Strategies

PROJECT SUMARY/ABSTRACT
Eradicating HIV from infected individuals is obstructed by the formation of a reservoir of persistent infected cells;
eliminating this reservoir could allow a cure for HIV infection. Recent research provides clues to approaches for
reservoir eradication. Rare, infected individuals, termed elite controllers (EC), control HIV without treatment with
antiretroviral medications. Analysis of HIV reservoirs in these individuals supports a model in which most
efficiently expressed HIV proviruses have been eliminated. Thus, integration sites of proviruses from ECs are
found enriched in genomic regions associated with heterochromatin and transcriptional repression. This overall
pattern is, however, violated by some clonally expanded infected cells with genic integrations that show ongoing
viral transcription. It has been suggested that these clones may have pro-survival and/or immune resistance
characteristics, but this remains poorly understood. Our team has shown that the above features can be
recapitulated by the application of CD8+ T-cell pressure in a novel mouse model of long-term infection, termed
the Participant Derived Xenograft (PDX) model. For this, T-cells are obtained from ECs and separated into
fractions. Naïve T cells are removed, which eliminates graft-versus-host disease upon transplantation into mice.
CD4+ memory T cells are transplanted into immunodeficient mice, then HIV is introduced. Autologous CD8+ T-
cells are introduced or not in controls, allowing experimental assessment of CD8+ T-cell pressure. In preliminary
data, in the presence of CD8+ T-cells, the selected proviral population is smaller and viral loads lower. Advanced
sequencing of integration site distributions shows larger clone sizes in the presence of CD8+ T-cell pressure,
and multiple features paralleling results in ECs, such as favored integration outside transcription units, integration
in reverse orientation relative to host transcription, and favored integration in more heterochromatic nuclear
compartments to name a few. Thus, we propose to use the PDX model, advanced integration site analysis, and
further tools to address the following Specific Aims: Aim 1. To define in high resolution the integration site
features that enable the persistence of HIV proviruses under extended in vivo selection by CD8+ T-cells and
compare the effects of diverse approach to enhancing this pressure. We will test multiple interventions in the
PDX model to increase CD8+ T-cell pressure, reverse latency or block its establishment, and characterize in
detail the molecular correlates. Aim 2. To train and validate multivariate statistical models to quantify the degree
of CD8+ T-cell selection on a given pro-viral landscape and use the models to infer selection in interventional
clinical trials. Completion of this study will thus provide advanced tools for quantifying CD8+ T-cell pressure on
populations of integrated HIV proviruses, rich information on the functions of latency and immune modulators in
the PDX model and in human trials, and an evaluation of the novel hypothesis that HIV insertional mutagenesis
can confer resistance to CD8+ T-cell-mediated killing.

Public health relevance
PROJECT NARRATIVE Antiretroviral therapies have transformed HIV into a manageable chronic condition but are burdensome and do not cure infection, in part because HIV integrates into the human genome as reactivatable proviruses. In some individuals, however, only proviruses integrated into deeply inactive parts of the genome remain – potentially representing a form of cure. This proposal will study and seek to enhance the ability of the cytotoxic (CD8) T-cell arm of the immune system to eliminate all but the most dormant proviruses and thus provide guidance to therapeutic approaches to curing infection.